Public health priority setting for environmental metals mixtures and birth defects

Birth defects are the leading known cause of infant mortality and one of the leading
sources of years of potential life lost. In fact, one out of every 33 live births in the United
States results in a birth defect. The lack of known, modifiable environmental factors associated
with birth defects remains a significant barrier to progress. In prior work, our team examined
exposure to arsenic, manganese, cadmium, and lead in relation to birth defects. We
have demonstrated that exposure to a toxic metals mixture through private well-water is
associated with increased risk for birth defects. Specifically, in areas where arsenic and
manganese co-occur, we observed higher-than-expected prevalence of birth defects. Current
filtration technology is sufficient to reduce exposures to many toxic metals.
Unfortunately, widespread adoption of filtration is infeasible due to cost, and there is a
substantial gap in knowledge about how to best intervene. Ideally, controlled experiments of water
filtration would be used to guide decisions about where to intervene, but, critically, obtaining
such data is prohibitively expensive. Thus, public health would be well served by using
existing, observational data to estimate the effects of such interventions. This innovative
project will use state-of-the-art statistical methods to directly quantify the impact of
potential interventions on toxic metal mixtures exposure as a strategy for reducing the
risk of birth defects. This approach can be used with varying levels of sophistication to adapt to
local public health needs. The overarching hypothesis of this proposal is that we can use routinely
collected surveillance data to identify the public health burden of birth defects in North Carolina
due to toxic metals exposures, as well as identify interventions to maximize reductions in this
burden under realistic constraints on cost and feasibility. We will test this hypothesis in three
specific aims. In Aim 1, we will estimate the risk of birth defects attributable to toxic
metal mixtures using data on well water contamination and 1.2 million NC births from
2003-2013 from the NC Department of Health and Human Services and the NC Birth
Defects Monitoring Program. We will apply a cutting-edge framework that combines Bayesian
methodology with a causal inference framework to estimate attributable risks from highly
correlated exposures. In Aim 2, we apply our framework to estimate the reductions in the
attributable risk of birth defects under potential interventions including filtration or changing
water sources. We will contrast birth defects risks under interventions that target areas of
concern, such as highly exposed areas, as a way to maximize reductions in birth defects. In Aim 3,
we will conduct a cost-effectiveness analysis in order to optimize available resources to reduce
birth defects. This work is a paradigm shift in how environmental mixtures can
be addressed. The results will provide stakeholders with data for effective decision
making. Importantly, our new approach to the analysis of environmental mixtures provides a
template for identifying priority exposures, areas, or groups to maximize the public health benefit
of policies on exposure mixtures in resource-limited settings.

Public health relevance
PROJECT NARRATIVE This project identifies optimal public health strategies to reduce birth defects resulting from exposure to a mixture of toxic metals in well water with a Bayesian causal inference framework. We apply this framework to evaluate targeted well water intervention strategies in North Carolina. This method holds exceptional promise for accelerating public health decisions about interventions related to exposure mixtures in the broader United States.